Sex-biased, region-specific regulation of DA release and clearance

Project Summary / Abstract
Virtually all neuropsychiatric disorders display sex bias, with the prevalence, age of onset, and clinical
symptomology differing significantly between males and females. Historically, female subjects have been
excluded from preclinical research, with male-only studies in neuroscience research outnumbering those of
females by 5.5:1, a discrepancy attributed to concern over the impact of estrus cycling on population
homogeneity or the assumption that sexual dimorphism is absent, such that results obtained with males
extrapolate to females. However, accumulating evidence demonstrates that genetic/gonadal sex and sex
hormones influence several critical brain functions including the release, reuptake, and signaling response to the
neurotransmitter dopamine (DA). DA is heavily implicated in substance use disorders and, notably, when
compared to men, women typically report experiencing greater subjective effects from psychostimulants, are
nearly twice as likely to abuse these drugs, and display enhanced dopamine release in the nucleus accumbens
(NAc), a critical component of the mesolimbic dopaminergic reward circuit, following psychostimulant exposure.
Similarly, in rodents, there are robust sex differences in the behavioral impacts of the psychostimulant
amphetamine with females exhibiting greater amphetamine place preference scores but blunted
hyperlocomotion relative to males. Though existing evidence points to a critical role for gonadal hormones in
determining differential psychostimulant responses in females, the neural substrate(s) linking steroid hormone
signaling to synaptic DA availability remain unelucidated. We recently described a sex-biased and region-specific
functional coupling between the dopamine transporter (DAT), a direct target of psychostimulants and primary
mediator of synaptic DA clearance. More specifically, the ability of D2 autoreceptors (D2ARs) to promote
phosphorylation and surface trafficking of DAT occurs in the dorsal striatum, the critical efferent target of
nigrostriatal dopamine neurons heavily implicated in DA-driven locomotor behavior but is absent in the reward-
linked NAc of male mice. In contrast, a functional coupling between D2AR and DAT is observed only in the
ventral striatum (NAc) in females. The central hypothesis of this proposal is that gonadal hormone signaling
differentially enhances D2AR-dependent DAT regulation in the nigrostriatal vs mesolimbic dopaminergic circuits
translating into sex-selective impacts of AMPH on synaptic DA and behavior. First, we will establish if/when the
actions of gonadal hormones in the brain define sex-biased patterns of D2AR effector coupling and the specific
hormone/receptor signaling involved. Second, we will investigate how circuit-specific DAT regulation via D2AR
shapes amphetamine-dependent DA outflow and behavior in a sex-biased manner. Ultimately, delineating the
mechanisms contributing to the sex biased architecture of the dopaminergic circuitry is imperative and has the
potential to identify novel therapeutic targets for the treatment of mental illnesses including psychostimulant
dependence for which there are currently no available pharmacotherapies.

Public health relevance
Project Narrative Though virtually all neuropsychiatric disorders display sex bias in terms of prevalence, age of onset, or specific symptomology, historically, the field of neuroscience has confined investigations into fundamental mechanisms driving disease risk to the exclusive study of male subjects. In support of a biological basis for sex differences in the pathogenesis of mental illness, we have identified an intrinsic sex bias in the architecture of the dopamine system, a critical mediator of naturalistic- and drug-dependent reward and reinforcement. This proposal seeks to establish how biological sex shapes dopaminergic neurotransmission and the molecular, physiological, and behavioral actions of psychostimulant drugs with the goal of establishing biological definitions of psychiatric disorders that recognize the modulatory influence of sex and will allow for effective tailoring of therapeutic interventions.